Using The Internet For Tobacco Control In Small Business

Smoking prevalence is disproportionately high among low income populations. Improving tobacco control in small businesses could significantly impact smoking outcomes among low-income populations for three reasons: l) small worksites employ the majority of working adults; 2) small worksites are more likely to hire low income employees than larger corporations; 3) small worksites are less likely to address tobacco use. In Phase I, we propose to develop an interactive Web-based tobacco control application for use by small business employees and owners participating in a healthcare purchasing alliance. The employee version of the application will provide a tailored smoking cessation intervention; the owner version will provide assistance to small business employers in implementing organizational changes to support smoking cessation. Primary goals of Phase II are to fully integrate the Web-based application into the purchasing alliance range of products and services and to evaluate its impact on outcomes. The advantages of the proposed product are that it will be: (l) fully integrated into the service delivery program of the purchasing alliance, thereby ensuring its recurrent promotion through purchasing alliance and workplace initiatives; (2) demonstrated to be cost-effective through reduced healthcare utilization and absenteeism; and, (3) licensed and distributed to purchasing alliances nationally. PROPOSED COMMERCIAL APPLICATIONS: The goal of this Phase I proposal is to develop a consumer-friendly, Internet-based tobacco control application which supports individual and ORGANIZATIONAL BEHAVIOR CHANGE. Phase II will complete development of the product and will establish a preliminary marketing plan to healthcare purchasing alliances, managed care organizations, health insurance companies, and pharmaceutical companies that will be implemented in Phase III.